The roles of conserved domains of proteins from the BET family in transcriptional regulation

Accurate control of gene transcription is necessary for most cellular processes and dysregulation of
transcription underlies development and progression of many human diseases. Gene transcription is
regulated by a complex interplay of sequence-specific transcription factors, coactivator complexes, and
chromatin landscape. Chromatin readers are regulatory factors which translate modifications on histone
tails into specific transcriptional output. Most chromatin readers are subunits of large protein complexes
which remodel or modify chromatin. One of the exceptions is a bromodomain and extra-terminal domain
(BET) protein family. BET proteins are characterized by the presence of two bromodomain which allows
them to recognize acetylated lysine residues and an extraterminal (ET) domain which was proposed to
support protein-protein interactions. BET family members are conserved across eukaryotes from yeast to
humans and are required for maintaining global transcriptional programs in both healthy and diseased
cells. Consequently, BET proteins are a promising drug target for many human pathologies. Despite their
essential function in transcriptional regulation the specific roles of BET proteins are not well understood.
BET proteins have a modular architecture which includes bromodomains, ET domain and several other
highly conserved domains of mostly unknown biological significance. Our central hypothesis, supported
by preliminary data, assumes that BET protein domains other than bromodomains are important for the
roles of BET proteins in transcriptional regulation. We propose to employ the yeast model system for a
comprehensive investigation into the functions of all BET domains conserved between yeast and human
cells. Building on our prior work, we will focus on the mechanisms which direct BET protein association
with chromatin and participation of BET proteins in transcription initiation. We speculate that BET proteins
provide an interaction hub for recruitment of coactivator complexes during transcription initiation, and we
expect that specific domains of BET factors contribute to these activities. The results of the project will
significantly expand the models of transcriptional regulation in both yeast and human cells.
Characterization of the functions of individual BET protein domains may also lead to identification of
promising drug targets to modulate aberrant transcription and offer an alternative to non-selective
inhibition of BET bromodomains.

Public health relevance
Understanding of the roles of conserved domains of BET proteins in transcriptional regulation in yeast cells will provide important insights into the mechanisms regulating BET protein recruitment to chromatin and BET protein functions in facilitating gene transcription.